Fluoride in Tooth Dentin and Neurodevelopmental Outcome in a Canadian Cohort

Project Summary / Abstract
Water fluoridation is controversial. Over the past decade, concern about the potential toxicity of
fluoride has grown, but there are still questions. Most human studies of fluoride toxicity only
studied children who were exposed to high levels of fluoride and only a few studies measured
fluoride exposure during critical periods of development. Urine, which is commonly used to
quantify a person’s exposure to fluoride, reflects recent exposure and requires serial sampling to
measure fluoride during different periods of development. Our proposed study will analyze tooth
dentin – the tissue that lies beneath enamel – to measure the level and timing of fluoride
exposure. Tooth dentin is an optimal biomarker because it provides a historical record of both
serial and cumulative exposure to ingested fluoride. We will test the following specific aims:
Aim 1. To quantify prenatal, early childhood, and cumulative fluoride exposure levels using shed
baby teeth collected from 800 children; Aim 2. To test whether dentin fluoride concentrations in
baby teeth is associated with lower IQ scores (n=610) and attention problems (n=898); Aim 3.
To test whether the urinary and dentin fluoride concentrations impact thyroid hormones, and
ultimately IQ scores and attention problems. This study is innovative because it will employ
state-of the-art analytical methods to measure the level and precise timing of exposures to
fluoride and toxic metals in tooth dentin. The study capitalizes on an existing Canadian
pregnancy and birth cohort, the Maternal-Infant Research on Environmental Chemicals. We will
leverage existing data from our ongoing NIH-funded study to find out if fluoride exposure during
early brain growth alters children’s IQ scores and behavioral problems. In addition, we will test
the endocrine disrupting potential of fluoride during pregnancy. Our measurement of fluoride
exposure in tooth dentin and serial urine samples offers an unprecedented opportunity to test for
neurotoxic effects of early-life exposure to fluoride. The large sample size will let us find out if to
child sex, timing of exposure, or exposure to powdered infant formula impact fluoride’s toxicity.
Major contributions include: 1) quantification of exposure to fluoride during fetal development
and early childhood using dentin; and 2) results that will directly impact decision making
concerning the safety of fluoride exposure during fetal development and early childhood at levels
relevant to the U.S. and Canada. Given our archived resources, we will be able to accomplish
this study efficiently and cost-effectively.

Public health relevance
Project Narrative Controversy about the safety of water fluoridation has led scientific advisory groups to recommend additional research on fluoride toxicity. This study will use a novel biomarker (dentin) to rigorously test the safety of chronic fluoride exposure among potentially vulnerable populations at levels relevant to the U.S. and Canada. The use of the dentin matrix will allow us to measure chronic fluoride exposure levels and to identify the possibility of discrete periods of susceptibility.